Light Sheet Microscopy for Einstein Shared Facility

This proposal seeks funding to purchase the Zeiss Light Sheet 7 microscope for the Neural Cell
Engineering and Imaging Core (NCEI) of the Rose F Kennedy Center for Intellectual and
Developmental Disabilities Research (IDDR) at the Albert Einstein College of Medicine (Einstein).
The NCEI Core has served as a valuable shared facility for Einstein investigators for close to 35
years. During this the Core has received strong financial support from the Kennedy IDDR Center,
funded by NIH/NICHD Center grants, the Department of Neuroscience, and the school. In recent
years there has been marked increase in development and use of light sheet imaging approaches to
biological and biomedical research, facilitating comprehensive evaluations not otherwise easily
obtained. This provides unprecedented global perspective to tissue patterning, cellular
architectonics, and functional ensembles and long-range connectivity, and can lead to unanticipated
new insights. Establishment of a light sheet microscope facility will bring this important technology to
the Einstein community for the first time, and meet what has been understandably a significantly
growing demand. The ability to rapidly image large intact volumes of tissues and organs will be
invaluable to numerous NIH-funded investigators of the IDDR center and of the Neuroscience,
Medicine, Psychiatry and Behavioral Sciences departments, as well as others. In all cases, the
microscope will be transformational in their studies that call for examination of long distance neuronal
pathways, volume determinations, labeled specific cell sub-population counts and distributions, and
complex mixed cell-type arrays. The research projects have relevance to neurodevelopmental
disorders, cognition, addiction, neural plasticity, epilepsy, infanticide, atherosclerosis and vascular
remodeling, obesity, and stress and memory. The capabilities provided by the proposed microscope
would be a vital asset for Einstein researchers, permitting studies not otherwise readily possible,
enhancing productivity and potentiating novel biomedical insights.

Public health relevance
NARRATIVE If funded, the Zeiss Light Sheet 7 microscope (LSM) 880 with Airyscan will serve as a shared resource at the Albert Einstein College of Medicine. This will provide state-of-the-art rapid fluorescence imaging allowing reconstruction of whole mouse brain, and other large biological samples of interest. This technology will strongly influence advances in programs related to neurologic, vascular and hematologic pathologies, as well as other programs.